The International Mammalian Genome Conference

Abstract
The International Mammalian Genome Society (IMGS) was established in 1990 to foster and stimulate mammalian
genetics research in areas ranging from genome annotation, sequence comparison and functional genomics to
mutagenesis and quantitative trait analysis, and to represent the concerns of its members in their professional activities.
For over 30 years, the IMGS has sponsored the annual International Mammalian Genome Conference (IMGC), which
provides a forum for scientific and policy discussions, and a venue for scientists in training to network with leaders in
mammalian genetics and to present their work at an international venue. The objective is to provide support for the
annual IMGC meeting and scholarships for student and postdoctoral scholar attendance, particularly targeting URMs.
Previous conferences have been highly successful at providing a forum for the mammalian and biomedical genetic
community and a venue for student and postdoctoral scholars to present their research and interact with leaders in the
mammalian genetics community. Substantial enhancements have been implemented for these conferences with the goal
of improving the benefit of the IMGC to the broader mammalian genetics community and increasing participation by
scientists in training. The improvements include sessions on large-scale resources and infrastructure, phenotyping for
pre-clinical models, mentorship luncheons, and participation by scientists in training on the IMGS Secretariat. With recent
discoveries in human genetic analysis now being translated to functional studies in relevant model systems, the
importance of a meeting with a focus on the optimal utilization of these resources is clear.

Public health relevance
Narrative The International Mammalian Genome Conferences provide an essential annual venue that brings together mammalian and biomedical geneticists from across the world to interact, form new collaborations and plan new research programs with the goal of improving the use of mammalian models to improve the health and well-being of people. An important aspect of the conferences is the training and mentoring of young scientists. The first site of this proposal is Puerto Rico to specifically target URMs that are local to the meeting site.